NDPBRN Opioid Survey

PROJECT SUMMARY/ABSTRACT:
Dentists regularly encounter patients experiencing problematic substance use and recognize the importance
of screening for substance abuse; however, they have limited exposure to addictions training and generally
lack systems to aid in screening, intervention, and referral to addictions treatment. Several critical gaps exist
in our foundational knowledge regarding dentists’ implementation of SUD screening. First, most prior work in
this area has focused on implementation of tobacco, alcohol, and – more recently – opioid screening, with
very little work addressing dentists’ implementation of screening for other substances of abuse, particularly
cannabis and stimulants. Second, except for recent studies specific to opioid screening, most work in this
area is dated by nearly a decade. Third, very little information exists regarding implementation of brief
counseling, referral to treatment, or willingness to engage in other point-of-care interventions addressing
substance misuse and its associated harms. Finally, and perhaps the most notable gap, is the lack of
information regarding dentists’ training, motivational factors, and practice behavior related to screening
implementation with adolescent patients.
To address these gaps, the Substance Use Disorders Screening (SUDS) Study will conduct a national
survey of dental practitioners’ substance use screening practices among adolescent and adult patients
through the Network. Results of this survey will speak directly to implementation gaps and will inform the
development of training and implementation interventions that provide dentists with the necessary tools to
implement universal substance use screening, brief interventions, and referral to treatment (when
appropriate) confidently and competently. The Network Coordinating Center for the National Dental
Practice-Based Research Network will provide scientific, technical and administrative support for the
development, implementation, analysis and dissemination of the SUDS Study.

Public health relevance
PROJECT NARRATIVE The Substance Use Disorders Screening Study will conduct a national survey of dental practitioners’ screening practices for problematic substance use (for example, opioids, alcohol, tobacco) in their adolescent and adult patients. The survey will be carried out through the National Dental Practice- Based Research Network. Results will help researchers develop screening tools, brief interventions and treatment referral procedures that can be used in the dental setting.